Project 3: Targeting IDH mutant gliomas

PROJECT SUMMARY
Lower grade gliomas, as well as the high grade gliomas that arise from them, are now diagnostically defined by
the presence of mutations in genes encoding isocitrate dehydrogenase (IDH) enzymes. Mutant IDH enzymes
exhibit the neomorphic ability to synthesize the oncometabolite (R)-2HG. (R)-2HG accumulates to millimolar
levels in IDH-mutant glioma cells and competes with a structurally similar metabolite, 2-oxoglutarate (2OG), for
binding to 2OG-dependent enzymes. These enzymes include dioxygenases that promote DNA and histone
demethylation. Consequently, (R)-2HG accumulation in IDH-mutant cells causes chromatin hypermethylation
and epigenetic reprogramming, ultimately leading to oncogenic signaling, a block in differentiation, and
malignant transformation. Recently, an inhibitor of mutant IDH (IDHi) oncoproteins, vorasidenib, was shown to
dramatically enhance progression-free survival of patients with grade 2 IDH-mutant glioma in a large-scale
multi-center phase 3 trial, setting the stage for promulgation of vorasidenib (and similar IDHi drugs) as new
“standard-of-care” therapies for these brain tumors. Patients in this study did, however, experience progression
on IDHi therapy, indicating that widespread use of these agents will create a new molecular brain tumor cohort:
post-IDHi recurrent IDH-mutant glioma. Developing new treatments tailored to the unique biology of this glioma
cohort is an emergent, unmet clinical need. Against this backdrop, our group has developed two treatment
strategies that hold promise for combating acquired resistance to IDHi therapy. These strategies seek to
exploit, rather than inhibit, mutant IDH activity by targeting synthetic lethal vulnerabilities conferred by the (R)-
2HG oncometabolite. We discovered that (R)-2HG accumulation sensitizes IDH-mutant glioma cells to
inhibitors of de novo pyrimidine nucleotide synthesis and NAD+ metabolism. These dependencies can be
targeted with orludodstat, an inhibitor of the pyrimidine synthesis enzyme dihydroorotate dehydrogenase
(DHODH), or with temozolomide (TMZ) and poly(ADP-ribose) glycohydrolase (PARG) inhibitor combination
therapy, respectively. Our central hypothesis is that these synthetic lethal treatments will serve as effective
second line therapies for IDH-mutant gliomas with IDHi acquired resistance. We will test this hypothesis
through three specific aims. In Specific Aim #1, we will create neurosphere, organoid, and genetically
engineered mouse models of IDH-mutant lower grade glioma with IDHi acquired resistance and use them to
test the antitumor activity of orludodstat. In Specific Aim #2, we will use these models and others to test the
impact of IDHi resistance on the antitumor activity of combined TMZ and PARG inhibitor therapy. In Specific
Aim #3, we will use primary samples from a window-of-opportunity trial of orludodstat in grade 2 IDH-mutant
glioma patients who have progressed on IDHi therapy to assess molecular markers of target engagement and
antitumor efficacy associated with this drug. If successful, these studies will nominate new treatment strategies
for patients with IDH-mutant glioma who have failed IDHi therapy and facilitate their clinical translation.

Public health relevance
PROJECT NARRATIVE Mutations in genes encoding isocitrate dehydrogenase (IDH) enzymes define subtypes of lower grade glioma in adults and can be targeted with mutant IDH inhibitor drugs, which delay the progression of these tumors. To combat resistance to mutant IDH inhibitor drugs, we propose to test two treatment strategies designed by our group to exploit vulnerabilities in glioma cells that are caused by IDH mutations. We will test these strategies in preclinical brain tumor models and in patients with IDH-mutant gliomas that do not respond to mutant IDH inhibitor drugs, thereby contributing to the development of new treatment options for this disease.